HIV, Depression, and Insulin Resistance

PROJECT ABSTRACT
Diabetes is a key driver of serious non-AIDS events in people with HIV (PWH). Depression potentially
contributes to new-onset diabetes in PWH. Collectively, our preliminary data indicate that successful
depression treatment with internet cognitive behavioral therapy for depression (iCBT-D) could reduce diabetes
risk in PWH by improving gut integrity, reducing monocyte activation, and preventing worsening insulin
resistance. In addition, our data suggest that examining the metabolome may elucidate new mechanistic and
potentially therapeutic pathways linking successful depression treatment to improved insulin resistance.
However, these promising findings are preliminary and require confirmation in a sufficiently powered RCT. Our
multidisciplinary group of investigators propose the following Specific Aims: Aim 1: To determine the effects of
iCBT-D on insulin resistance in depressed PWH on ART. We hypothesize that iCBT-D, compared to active
control, will prevent worsening insulin resistance as measured by HOMA-IR at 24 weeks. In secondary
analyses, we will also compare changes in HbA1c and glycated albumin as endpoints more proximal to
diabetes diagnosis. Aim 2: To determine the effects of iCBT-D on monocyte activation in depressed PWH on
ART. We hypothesize that iCBT-D, compared to active control, will lead to reduced circulating sCD14,
sCD163, and CD14+CD16+ intermediate monocyte levels at 24 weeks. In secondary analyses, we will
examine the effects of iCBT-D on markers of gut barrier integrity (REG3α) and microbial translocation (16S
rDNA and β-D-glucan). Aim 3: To determine the effects of iCBT-D on metabolomic profiles in depressed PWH
on ART. We hypothesize that iCBT-D, compared to active control, will result in changes in the circulating
metabolome at 24 weeks. We will then perform formal pathway analysis based on differential metabolite
profiles to identify novel mechanistic biologic mechanisms to explain the treatment group - HOMA-IR
relationship. We will test these hypotheses by conducting a 48-week RCT comparing iCBT-D with an active
control comparator group (depression education, depressive symptom monitoring, and current care for
depression in the HIV clinics) in 150 depressed PWH on ART. The primary analyses will be performed at the
24-week timepoint with similar secondary analyses performed at the 48-week timepoint to assess duration of
response. Given the high prevalence of depression in PWH of up to 40%, depression treatment could have
significant and widespread benefits by preventing diabetes in addition to its mental health importance. Thus,
this application meets the stated objectives of PAS-24-163, “Priority HIV/AIDS Research within the Mission of
NIDDK.”

Public health relevance
NARRATIVE This proposal will fill a critical gap in our knowledge by determining the effects of depression treatment on insulin resistance, monocyte activation, and the metabolome in ART-treated people with HIV. The results from this randomized, controlled trial will identify new treatment targets and lay the rationale for a future, large-scale trial of internet CBT for depression treatment to reduce incident diabetes in HIV.